2025 Chronobiology Gordon Research Conference and Gordon Research Seminar

Project Summary
We request partial support for the 23rd Chronobiology Gordon Research Conference (GRC) and the
associated 6th Gordon Research Seminar (GRS) “Circadian Clock Dynamics and Physiology Across Biological
Scales”. The 23rd Chronobiology Gordon Research Conference (GRC) and the associated 6th Gordon
Research Seminar (GRS) will take place from July 5 to 11, 2025 at the Rey Don Jaime Grand Hotel in
Castelldefels, Barcelona, Spain. The theme of the 2025 GRC meeting, “Circadian Clock Dynamics and
Physiology Across Biological Scales”, reflects the breadth of chronobiology across the domains of life and its
integration with physiology, metabolic health, neuroscience, mental health, sleep and aging, areas falling within
the core missions of NINDS. The GRS will focus on training and mentorship, while the GRC will present the
latest unpublished work from both senior and emerging stars of the field. Apart from mentorship activities, the
GRS will feature 20 trainee speakers, one of whom will be promoted to give a short talk at the GRC along with
other 20 scientists selected from abstracts, providing a valuable learning experience for the trainees and early
career scientists. Members of our Diversity Committee will help select the “late-breaking” talks, as well as
shaping our recruitment efforts and our program. A new “Chronobiology Network Program” will offer funding to
trainees from underrepresented groups selected for their potential to help transform our field. Program
members will meet with two mentors in the field during the meeting, will assist with the Power Hour, and will be
integrated into a small but diverse network of previous recipients of URM-directed fellowships in chronobiology
(e.g., Carl Storm Underrepresented Minority Fellowship, GRC).

Public health relevance
Project narrative Circadian or daily rhythms shape physiology and behavior, most obviously in the regular timing of the sleep- wake cycle. These rhythms are kept to the correct timing by their responses to light and other environmental signals of time of day, but modern life can lead to severe disruptions of these daily rhythms, with many people suffering from fragmented sleep, low energy, and mood disorders and recent research demonstrating links between circadian disruption and metabolic health, cancer, and cardiac function. The GRC/GRS Chronobiology conference will allow researchers to share the latest findings and to develop stronger understanding of these processes, with the aim of improving human health.